Targeting monocyte derived macrophage for stroke treatment

Crosstalk between the central nervous system and the immune system is known to steer the progression of
ischemic brain injury. However, there are no clinical treatments that can harness the power of the immune system
to temper inflammation-induced secondary injuries or promote brain repair. The reasons for this gap are
multifactorial, including preclinical emphases on young animals of the male sex and a lack of understanding of
cellular and molecular mechanisms underlying stroke outcomes. We have discovered that monocyte-derived
macrophages (MDMø) partly drive sex-dependent stroke outcomes. Further mechanistic elucidation of sex and
age distinctions in MDMø responses and their significance in stroke outcomes may identify viable targets for
brain protection and repair in patients of both sexes.
We performed single-cell RNA sequencing analyses of brain cells collected from young male and female mice
at 5d after transient (60 min) middle cerebral artery occlusion (tMCAO) and found sex-specific clustering of
MDMø, with high galectin 3 (Gal3) expression in male MDMø. Gal3 is a carbohydrate-binding molecule and a
modulator of inflammation. Higher blood levels of Gal3 in the acute stage after stroke are associated with worse
outcomes in patients. Previous animal studies document diverse roles of Gal3 in cerebral ischemiadepending
on the stage of stroke evolution. However, the cell-specific functions of Gal3 in MDMø after stroke remain elusive.
Our pilot data suggest that Gal3 is an age and sex-dependent modulator of damaged lysosome-mediated
inflammation in MDMø. 1) Gal3 expression in MDMø is much higher in young male mice and aged mice of both
sexes vs. young females early after tMCAO. 2) Gal3 deficiency reduces lysosomal accumulation and
inflammasome activation in MDMø and alleviates ischemic brain injury 3d after tMCAO. 3) Exposure to dead
ischemic neurons results in higher lysosomal accumulation of Gal3, lysosome leakage, inflammasome activation,
and inflammatory cytokine production in male vs. female Mø; and these deleterious effects are mitigated by a
selective Gal3 inhibitor, TD139. 4) Transient post-stroke TD139 treatment inhibits neuroinflammation, reduces
brain infarct, and improves long-term neurological functions in young and aged male mice.
The proposed work will elucidate the significance of Gal3 in MDMø responses in young and aged mice of both
sexes and will develop TD139 as a novel strategy to improve stroke outcomes. The central hypothesis is that
high Gal3 expression in MDMø after stroke increases accumulation of damaged lysosomes, leading to
inflammasome activation in MDMø and worse outcomes. Transient Gal3 inhibition early after stroke
ameliorates brain injury and improves long term outcomes in young and aged mice of both sexes. Aim 1: Test
if Gal3 expression in MDMø plays a role in acute brain injury after stroke. Aim 2: Test if high Gal3 expression
leads to lysosomal accumulation and enhances NLRP3 inflammasome-dependent pro-inflammatory/neurotoxic
responses in MDMø. Aim 3: Test the effects of TD139 in young and aged mice of both sexes after stroke.

Public health relevance
Post-stroke immune responses are important in determining the progression of ischemic brain injury. This study will explore galectin 3 as a modulator of damaged lysosome-mediated inflammation in monocyte-derived macrophages after stroke. We will investigate whether high galectin 3 expression after stroke increases accumulation of damaged lysosomes in macrophages, leads to exacerbated inflammation, and worsens outcomes. Our findings will help direct the development of galectin 3 inhibition as a potential new therapy to reduce ischemic brain injury and improve long term outcomes after stroke in young and aged patients of both sexes.